Re-educating T cell-mediated immunity in SIV by modulating metabolic pathways

Project Summary/Abstract
HIV/AIDS is a chronic infectious disease that affects around 37 million people worldwide. CD8 T cells play a
critical role in controlling HIV infection. However, CD8 T cells become exhausted over time due to continuous
stimulation. Exhausted HIV-specific CD8 T cells, characterized by elevated expression of inhibitory receptors
(e.g. PD-1), positively correlate with higher viral load, impaired T cell function, and disease progression. In HIV
and other chronic viral infections, exhausted antigen-specific CD8 T cells expressing PD-1 can create a
suppressive environment suggesting that such cells not only have a direct role in disease progression but can
cross-talk with other immune cells to impair their function. Chronic HIV infection dysregulates T cell energy
metabolism. HIV-specific CD8 T cells isolated from infected individuals exhibit elevated mitochondrial stress
which is still apparent years after antiretroviral therapy (ART). PD-1 expression on T cells is associated with
mitochondrial stress. PD-1-mediated signaling dysregulates T cell mitochondrial energetics by reducing
glycolysis and shifting towards fatty acid b-oxidation and oxidative phosphorylation (OxPhos). Metformin is an
FDA-approved drug that dampens OxPhos by inhibiting mitochondrial complex I. To date, most studies
investigating metformin use in HIV+ individuals are often in the presence of ART. It has yet to be explored how
modulating energy metabolism with metformin impacts host immunity in an ART-naïve setting. HIV not only
impairs immune control of the viral infection, but also increases susceptibility to opportunistic infections. People
living with HIV are incredibly susceptible to the tuberculosis-causing bacilli, Mycobacterium tuberculosis (Mtb).
We previously showed SIV-infected Mauritian cynomolgus macaques (MCM) to be more susceptible to Mtb,
which we attributed to immunologic impairment by preexisting SIV infection. Therefore, Mtb challenge is a
stringent assessment of host defenses and, given the prevalence of HIV/Mtb co-infection, has great relevance
to global health.
In this K01 proposal, we will identify pathways involved in energy metabolism in CD8 T cells during chronic HIV
infection and reveal their role in T cell exhaustion using our established MCM model of HIV. We will use a
comprehensive analytic approach that combines single cell RNA sequencing, metabolic assays, and flow
cytometry to assess the role of T cell metabolism in SIV-infected MCM. We will alter metabolism using metformin
to reprogram CD8 T cells and determine whether this metabolic reprogramming improves host immunity by
challenging SIV+ animals with Mtb.

Public health relevance
Project Narrative Chronic HIV infection causes T cell exhaustion resulting in impaired control of the ongoing viral infection as well as increased susceptibility to opportunistic infections. Mechanisms that regulate exhaustion are not yet fully characterize. In this study, we will determine pathways involved in energy metabolism in T cells during chronic HIV and reveal their role in T cell exhaustion.